Control of COPII vesicle trafficking by intracellular protein glycosylation

Project Summary/Abstract
One third of eukaryotic proteins transit the secretory pathway for sorting to specific locations, including
the endoplasmic reticulum (ER), Golgi, plasma membrane or extracellular milieu. Since misdirected proteins
cannot function, the secretory pathway is critical for establishing and maintaining normal cell and tissue
physiology. The COPII coat protein complex, which mediates anterograde trafficking from the ER, is a key control
point for protein targeting. Indeed, mutations in COPII genes cause a range of human diseases, including cranio-
lenticulo-sutural dysplasia (CLSD), a subtype of osteogenesis imperfecta (OI), hematologic disorders and myriad
neurological defects. Detailed knowledge of COPII trafficking is required to understand its role in cell physiology
and to treat disorders in which it is disrupted. However, while the core COPII machinery is well defined, little is
known about how vertebrate cells regulate COPII activity in response to normal or pathological signals or stress.
We and others have found that several COPII proteins are modified by O-linked b-N-acetylglucosamine
(O-GlcNAc), a dynamic form of intracellular protein glycosylation. At the start of the prior project period, the
effects of O-GlcNAcylation on COPII remained almost entirely unknown. Since then, we have defined the scope
of O-GlcNAcylation in the core COPII system, identified functional effects of O-GlcNAc cycling in vesicle
trafficking, devised new quantitative glycoproteomics methods to profile O-GlcNAc changes in response to
secretory pathway stress and other stimuli, and demonstrated that particular Sec23A O-GlcNAc sites are
required for endogenous collagen trafficking in cultured human cells and in the chondrocytes of developing
zebrafish. Together, these results demonstrate that site-specific O-GlcNAcylation of COPII proteins governs
cargo trafficking in vertebrate cells and tissues. However, major unanswered questions remain, including the
mechanistic effects that O-GlcNAc exerts on COPII proteins, the upstream stimuli that modulate COPII O-
GlcNAcylation and the global landscape of O-GlcNAc signaling in the early secretory pathway. Here, we propose
to address these important questions in the next award period.
In Aim 1, we will dissect the molecular mechanisms by which O-GlcNAc cycling influences COPII vesicle
trafficking. In Aim 2, we will identify upstream stimuli that control COPII protein O-GlcNAcylation and determine
the downstream effects of this signaling in protein secretion and cell cycle progression. In Aim 3, we will use our
glycoproteomics methods to canvass proteome-wide O-GlcNAc signaling in response to COPII cargo trafficking,
and provide an integrated picture of crosstalk between O-GlcNAcylation and phosphorylation in protein secretion.
Our work will shed new light on how O-GlcNAc regulates trafficking in cells and tissues, and may reveal new
opportunities to treat diseases of COPII dysfunction by manipulating protein glycosylation.

Public health relevance
Project Narrative Our project focuses on COPII, a system of proteins that transports cargoes from one part of the cell (the endoplasmic reticulum) towards another (the Golgi). COPII is required for healthy cell and tissue physiology, and mutations in COPII genes cause a variety of inherited human diseases of the nervous system and skeleton, yet the mechanisms that cells use to regulate COPII activity are largely unknown. We will take an interdisciplinary approach to study an emerging form of COPII regulation in which sugars are attached to COPII proteins to adjust their functions.